Brain-region-specific humanized cortical interneuron mice

Abstract
GABAergic cortical interneurons (cINs) play critical roles in balancing, synchronizing, and gating brain activity
by inhibiting other neurons. Their malfunction, especially those of medial ganglionic eminence (MGE)-derived
cINs, has been associated with various neurodevelopmental brain disorders, such as schizophrenia (SCZ) and
autism spectrum disorders (ASD). Considering the fact that the divergence between human brains and rodent
brains has resulted in the failure of many central nervous system (CNS) therapeutics validated in rodent
models, it is critical to study human neurons to better understand the mechanisms of these cIN-associated
brain disorders. Human fetal brain tissues are not accessible for mechanistic studies, but we have developed a
method to efficiently generate homogeneous populations of MGE-type human cINs from pluripotent stem cells
(PSCs) of healthy or diseased subjects. We have extensively characterized them and demonstrated their
authenticity and functionality, making it possible to study the converging functional consequences of complex
genetics in real patient neurons, which cannot be studied in mouse neurons due to a lack of conservation of
non-coding regions, where most of risk loci are present. However, in vitro cultured neurons lack other critical
components of the brain environment, such as astrocytes, oligodendrocytes, microglia and blood vessels,
which can significantly impact their function. There have been efforts to optimize in vitro culture systems to
better recapitulate in vivo physiological environments by adding other brain cellular components, but there are
still limitations as to how closely they can simulate in vivo situations. To resolve this issue, in our previous
study, we pioneered human neuron-mouse brain chimeras to study the function of human SCZ neurons in
physiological environments. Although we were able to successfully identify SCZ cIN-intrinsic connectivity
deficits in mouse brains, we were not able to analyze the impacts of grafted neurons on brain circuits and
behaviors due to the presence of healthy mouse neurons in the grafted mice. Thus, in this proposed study, we
will perform brain-region-specific cIN-ablation in NodScid gamma (NSG) mice, followed by the replacement of
ablated host cINs with human cINs to generate region-specific humanized cIN chimeras. Based on previous
studies, including ours, that show successful restoration of compromised mouse inhibition by grafted human
cINs, these mice will allow us to analyze the functional impacts of grafted human cINs on the brain circuits and
behaviors in physiological in vivo environments. This novel physiological model system will help us tease apart
cell-type- and brain-region-specific disease mechanisms for complex brain disorders, and aid in developing
novel therapeutics.

Public health relevance
Narrative Human iPSCs can provide unlimited sources of human neurons to study disease mechanisms; but in vitro neuronal cultures lack many important brain components that play crucial roles in neuronal functions. Thus, we will generate brain-region-specific humanized cortical interneuron mice to allow for the study of the role of grafted human neurons in brain circuit and behavioral functions. Such physiological humanized models will facilitate the understanding of cell-type-specific and brain-region-specific disease mechanisms, and the development of novel therapeutics.